G-RISE at Auburn University

PROJECT SUMMARY
The mission of G-RISE at Auburn University will be to embody the concepts of inclusive
excellence while enhancing research in biomedical sciences. This program fits perfectly
with multiple ongoing efforts at Auburn and will synergize with these efforts. Auburn's recent
attainment of R1 status recognizes the breadth of excellent research occurring at the
university. This proposal will help to develop a diverse pool of highly-trained scientists with
the technical, operational and professional skills needed to conduct ethically responsible,
rigorous research in careers in the biomedical research workforce. Auburn provides a
unique environment in which these G-RISE scholars will flourish, due to our strength in
interdisciplinary science and our emphasis on supporting and nurturing all members of the
“Auburn Family”. The latter is embodied in the constellation of mentoring approach taken in
this proposal. Mentoring goes far beyond the identification of a research mentor. Leveraging
existing underutilized capacity, mentoring will include a wholistic approach to ensuring
student success. Faculty will also benefit from the training implemented through this
proposal, making them stronger researchers and better teachers. While the training will be
focused on members of the program, it will be open to any interested student or faculty
member, and will create a positive impact across the entirety of Auburn's biomedical
research endeavor. Auburn is committed to the success of this program, at all levels.

Public health relevance
PROJECT NARRATIVE G‐RISE at Auburn University is designed as an umbrella to enhance diversity in graduate programs focused on doctoral degrees in the biomedical sciences. Programmatic activities are focused on recruiting, admitting, and supporting six highly qualified students yearly from underrepresented groups through multiple mechanisms, with common threads of inclusive excellence and mentoring constellations. Given the history of racial inequities and the demographic composition of the region, G‐RISE at Auburn will focus on African‐American, Latinx, and Native American students in recruiting efforts, but will welcome all applicants.